RSPO2-LGR4 signaling in atherosclerosis

PROJECT SUMMARY
Recent investigations utilizing cell-lineage tracing, single-cell RNA-sequencing (scRNA-seq), and genomic
approaches have revealed a crucial role of vascular smooth muscle cells (VSMCs) in atherosclerosis. These
cells regulate the phenotype of other types of arterial cells via secreting various soluble factors, transform into
lipid-laden foam cells, and undergo dedifferentiation into synthetic phenotype cells, contributing to the
development of atherosclerosis. Additional studies identified an indispensable role of the lymphatic network in
the removal of cholesterol and inflammatory cells/cytokines from the arterial wall, thereby inhibiting
atherosclerosis. Moreover, surgical and genetic disruption of lymphatic drainage leads to aggravated
atherosclerotic lesion formation. However, our knowledge of the endogenous factors and mechanisms regulating
arterial lymphangiogenesis and VSMC phenotype remains limited. We have recently reported the elevated
expression of a matricellular secretory protein R-spondin 2 (RSPO2) in human and murine atherosclerotic
arteries, particularly in VSMCs, identified the anti-lymphangiogenic potential of RSPO2, and observed attenuated
atherosclerosis and improved arterial lipid drainage with blockade of periadventitial Rspo2-induced signaling.
Additional new data demonstrate increased LGR4 expression in atherosclerotic vascular tissue and reveal LGR4
as a predominant receptor for RSPO2 in lymphatic endothelial cells (LECs) and VSMCs. Besides, elevated
RSPO2 expression is detected in neointimal VSMCs of injured carotid arteries in mice. However, the autocrine
and paracrine roles of VSMC-secreted Rspo2 in regulating arterial lymphangiogenesis, VSMC phenotypic
switch, and atherosclerosis development remain unknown. Based on these findings, our central hypothesis is
that VSMC-derived Rspo2 via interacting with Lgr4 promotes atherosclerosis. In Aim 1, we will determine the
functional role of VSMC Rspo2 in regulating arterial lymphangiogenesis, lymphatic function, and atherogenesis
using in vitro studies and a novel SMC-specific Rspo2 knockout mouse model that we recently created. Aim 2
will focus on investigating the involvement of Lgr4 present in LECs in regulating arterial lymphangiogenesis and
atherosclerosis development (progression and regression) using inducible LEC-restricted Lgr4-deficient mice. In
Aim 3, we will explore the mechanisms responsible for the induction of RSPO2 levels in VSMCs and the
contribution of RSPO2-LGR4 signaling in VSMC phenotypic modulation (scRNA-seq), neointima formation, and
atherogenesis (in Lgr4-deficient mice) utilizing SMC-lineage tracing mice with Rspo2- or Lgr4-deficiency. The
successful completion of these studies will provide novel insights into the mechanisms governing arterial
lymphangiogenesis, VSMC phenotypic plasticity, and atherosclerosis development, and identify novel
therapeutic targets for atherosclerosis. To ensure the success of the proposed studies, we have assembled a
multidisciplinary team comprising a collaborator and consultants.

Public health relevance
PROJECT NARRATIVE Atherosclerosis and its associated cardiovascular disease remain a leading cause of death in the United States, posing a considerable burden on the US healthcare system. We have recently made a novel discovery that matricellular protein R-spondin 2 levels are elevated in atherosclerotic arteries, and it inhibits arterial lymphangiogenesis. The current proposal using integrative approaches, including multiple genetically engineered mice, viral vector-mediated gene deliveries, and cell-based assays, will focus on investigating the previously unknown function and underlying mechanisms of R-spondin 2-induced signaling in regulating lymphangiogenesis, vascular smooth muscle cell phenotype, and atherosclerosis.